The role of microbiota amino acid metabolism in cancer

Studies have shown that microbiota composition and their genes and metabolites differ between healthy and
cancer patients. However, unraveling their effect on cancer onset or development is challenging due to the lack
of an efficient system to manipulate their levels in vivo. Recently, we were able to precisely manipulate microbiota
amino acid depletion pathways in vivo and found that some pathways affect host amino acid homeostasis and
tumor progression. We hypothesize that the gut bacteria impact the host amino acid homeostasis and affect
tumor microenvironment (TME) and progression. Herein, we will identify the microbes (and their genes) that
actively deplete intestinal amino acids and evaluate how they affect TME and tumor progression. We will not
only learn more about the role of microbiota-mediated amino acid metabolism in cancer progression at the
molecular level, our work will also lay the ground for generating a synthetic and engineered gut microbial
community with defined metabolic functions to prevent and cure cancer. There are three convergent motivations:
First, many microbiota molecular features are different between healthy and cancer patients, and we need
functional studies to causally connect them with cancer. We will combine bioinformatics, metabolomics, bacterial
genetics, and germ-free and tumor mouse models to modulate microbiome metabolic pathways in the host. This
approach will boost a systematic identification of tumor-affecting microbiota genes and pathways; our findings
will also promote new therapeutic strategies by targeting these previously unknown microbial metabolic avenues.
Second, gut microbiota metabolism significantly impacts host nutrient homeostasis. However, the molecular
mechanisms behind how microbiota regulates host amino acid homeostasis and affects tumor progression
remain largely unexplored. We believe that this approach can be used to regulate the microbiome metabolic
functions at a specific niche to study their effects on cancer. Our finding would also open the door to interrogating
– and ultimately controlling – one of the most concrete contributions that gut bacteria make to host biology.
Third, a synthetic microbial community with a defined and programmable metabolic function has transformative
potential for cancer treatment. The gut microbiome is part of our `pan-genome,' whose metabolic functions are
more tractable by genetic manipulation or adjusting microbiota composition. Our approach will expedite the
genomic and biological characterization of microbiota metabolic genes, laying the basis for a synthetic
community with a defined and programmable metabolic function to prevent and cure cancer.

Public health relevance
The microbes living on/in the human body, known as “the human microbiota”, metabolize various dietary nutrients, train the human immune system, and are essential for human health. This proposal aims to dissect the molecular mechanisms behind microbiota and cancer association and provides mechanistic insights into microbiota pathways involved in mediating host amino acid homeostasis and affecting tumor onset and progression. It will also pave the way for systematically regulating these health-related microbial pathways in the human gut using synthetic biology and microbial genetics to promote cancer prevention and treatment.